Lysosome Regulation and Signaling in Aging and Alzheimer's Disease

This is an equipment supplement application for a Program Project Grant (P01AG066606, June
1, 2021-February 28, 2026, PI: Zheng, Hui). The overarching goal of the parent P01 is to
investigate the lysosome-to-nucleus signaling pathways regulating lysosomal homoeostasis in
aging and Alzheimer’s disease. The P01 consists of three highly interactive projects and two
scientific cores, which are overseen by an administration and data integration core. One of the
essential components of the P01 is Core C: Lysosomal Metabolomics and pH. The Core uses
high-throughput Mass Spectrometer-based metabolomics to assess changes in lysosomal
metabolic activity in aging and tauopathy. The Core C Leader, Meng Wang, is a Professor at
Baylor College of Medicine and an Investigator of the Howard Hughes Medical Institute (HHMI).
She owns a Thermo Orbitrap Fusion Lumos Tribrid Mass Spectrometer for the lysosomal
metabolomics experiments. Recently Dr. Wang has decided to leave Baylor and take on a new
position at HHMI Janelia Research Campus, effective August 1, 2022. The Janelia organization
is exclusively supported by HHMI and, as a result, Dr. Wang is no longer able to participate in the
PPG. In addition, since Dr. Wang purchased mass spec using the HHMI funds, she will need to
take the instrument to her new post. We have identified Dr. Feng Li, Associate Professor in the
Center for Drug Discovery and the Department of Pathology & Immunology at Baylor College of
Medicine and an expert in LC-MS metabolomics, to replace Dr. Wang as the leader for Core C.
We have discussed this change and the need for a mass spec with Dr. Paul Barrett, the PO of
the P01, who is supportive of the equipment supplement application to purchase a Thermo
Scientific™ Orbitrap Exploris 120 LC/MS system to perform lysosome-specific metabolomic
profiling as proposed in the parent P01.

Public health relevance
This is an equipment supplement application for a Program Project Grant (P01AG066606, June 1, 2021-February 28, 2026, PI: Zheng, Hui). This is needed to pursue the experiments and goals proposed in the P01.